Protocol Review and Monitoring System

PROTOCOL REVIEW AND MONITORING SYSTEM (PRMS)
PROJECT SUMMARY/ABSTRACT
The Case Comprehensive Cancer Center (Case CCC) Protocol Review and Monitoring System (PRMS) is
responsible for the scientific evaluation, prioritization, and monitoring of all cancer clinical research studies
conducted at the Center's consortium institutions. The PRMS is independent of, and therefore complementary
to, the Institutional Review Boards and the Data Safety and Toxicity Committee. The PRMS encompasses
activities of the Clinical Research Disease Teams and Protocol Review and Monitoring Committee (PRMC), with
close interaction between these entities. The Case CCC Clinical Research Office (CRO) oversees the PRMS,
as the central coordinator of clinical trials operations (e.g. Clinical Protocol and Data Management), and
associated committees (PRMC, Data Safety and Toxicity, Minority Accrual, and Clinical Research Operations
Committee). The CRO is a critical resource for investigators across the consortium, at Case Western Reserve
University and at its clinical sites, Cleveland Clinic and University Hospitals. The PRMC supports the research
programs of the Case CCC by providing scientific review and feedback (including feasibility assessment),
establishing prioritization, and monitoring progress of and patient accrual in active clinical research studies. The
PRMC membership is selected to ensure diverse expertise relevant to cancer clinical research and is composed
of clinical investigators, investigational pharmacists, registered nurses, biostatisticians, translational scientists,
behavioral scientists, and patient advocates from consortium member institutions. The PRMC operates as a
single committee across the Case CCC consortium and reviews all new clinical cancer research protocols,
including those sponsored by the Center, NCI, other NIH, industry, foundations, or other sources. These include
interventional (treatment, preventive, supportive, diagnostic), and non-interventional studies (ancillary,
correlative [tissue-based], and observational studies). The PRMC has authority to close ongoing studies that are
not meeting accrual or performance standards and are unlikely to accomplish their scientific goals, and a
structured process for accrual monitoring and evaluation is followed. All new protocols and protocol amendments
that include scientific changes, such as revisions in objectives/endpoints, eligibility, treatment/dosing,
biostatistics, and sample collection, are evaluated by the PRMC. In 2023, there were 869 active interventional
studies at Case CCC monitored by the PRMC. The PRMC reviewed 372 new studies (full board review: 340;
administrative review: 32). The PRMC also reviewed 536 amendments.